Project 3: Targeting PRMT5 in Mantle Cell Lymphoma

Project 3 Summary
Mantle cell lymphoma (MCL) is an incurable B-cell lymphoma characterized by aberrant genetic and epigenetic
events. A variety of therapeutic strategies have been used to improve the outcome of MCL patients including
immune-chemotherapy and stem cell transplantation. Approaches targeting the B cell receptor (BCR) signaling
pathway with ibrutinib have shown promise, however, outcome data is immature and emerging resistance is
clearly evident. Thus there remains a clear, unmet need for novel therapeutic approaches for treating MCL. We
have shown that PRMT5 is selectively over expressed in MCL and drives global repressive epigenetic marks
on chromatin to silence regulatory and tumor suppressor genes. PRMT5 knock down with shRNA promotes
selective MCL toxicity which led us to hypothesize that PRMT5 is an attractive target for this disease. We have
developed a “first-in-class” drug that selectively inhibits PRMT5 activity with IC50 in low nM range. Our lead
drug is toxic to lymphoma, not normal B cells, is well tolerated in vivo with impressive anti-tumor activity in
preclinical animal models of MCL. PRMT5 inhibitors have been used as chemical probes to dissect out critical
pathways utilized by MCL tumor cells. Preliminary whole genome mapping with antibodies specific for PRMT5
epigenetic marks and whole transcriptome sequencing (RNA-Seq, in collaboration with WCM) in presence and
absence of PRMT5 inhibitors has revealed a broad range of signaling, survival and growth pathways to be
governed by this enzyme. Our preliminary work has found that PRMT5 directly targets regulatory genes such
as PTPROt, TRIB3, and PIK3IP1 which negatively regulate BCR and PI3K/AKT pathways. Inactivation of
constitutive AKT activity leads to dephosphorylation of FOXO1, promoting its epigenetic regulation of anti-
cancer gene expression. We discovered that PRMT5 inhibition leads to direct de-repression of multiple micro-
RNAs that may deplete CYCLIN D1 leading to activation of RB and restoration of the RB/E2F regulatory
network. Consequently, PRMT5 inhibition leads to RB/E2F-mediated silencing of EZH2, SUZ12 and EED,
components of the epigenetic repressor PRC2 complex, a family of lysine methyltransferase enzymes that are
frequently mutated and activated in MCL. Thus, by inhibiting PRMT5, we can achieve direct inhibition of
repressive arginine epigenetic marks while indirectly depleting lysine repressive marks like H3K27(Me3) and
possibly, targets of FOXO1. Our strategy to inhibit a central player like PRMT5 has led to a novel approach to
restore regulation to the MCL cell at multiple levels including the epigenome, BCR, PI3K/AKT, and CYCLIN
D/RB-E2F pathways. We have proposed integrative whole genome approaches and strategies utilizing
innovative preclinical MCL models to examine how PRMT5 inhibition can circumvent drug resistance
encountered with novel molecularly targeted agents examined in clinical trials and preclinical work proposed in
Projects 1 and 2. We present an innovative, straight-forward and robust approach to discover the genetic
programs altered in MCL and will use this information to develop new strategies to treat this incurable disease.

Public health relevance
Project Narrative Recent work by our group has identified the PRMT5 enzyme as an ideal therapeutic target to treat mantle cell lymphoma (MCL), an incurable disease associated with survival of 3-5 years despite aggressive, multimodal therapy. We have developed a “first in class” drug that selectively kills MCL tumor cells, but not normal cells, and propose a plan to use this drug (1) as a therapeutic agent in preclinical MCL in vivo models and (2) as a chemical probe to characterize the epigenetic programs that are governed by this enzyme. We believe we are uniquely poised to (1) discover how PRMT5 dysregulation leads to global anti-cancer gene silencing in MCL; (2) mechanistically address how PRMT5 inhibition can affect critical pathways that drive MCL growth and survival; and (3) develop novel therapeutic strategies to improve the outcome of patients with MCL. !